YAP1, neointima formation, and blood pressure regulation

PROJECT SUMMARY

Vascular smooth muscle cell (VSMC) phenotypic modulation is central to the etiologies of multiple vascular wall
diseases. In post-­angioplasty restenosis and atherosclerosis, VSMCs acquire a proliferative/migratory
phenotype leading to neointima formation. In contrast, hypertension is largely caused by increased vascular
resistance that is attributed to exaggerated VSMC contraction and vascular remodeling. Identification of the key
players that regulate VSMC proliferation and contraction is critical for further understanding of the underlying
mechanisms of VSMC-­driven vascular wall diseases and also for developing novel therapeutic approaches. We
have previously demonstrated that the transcription co-­factor yes-­associated protein 1 (YAP1) promotes VSMC
proliferation. Yet, the role and underlying mechanisms of YAP1 in neointima formation in vivo remain unclear.
Furthermore, recent genome-­wide association studies (GWAS) have identified a loss-­of-­function single
nucleotide polymorphism (SNP) in YAP1 gene locus that was unexpectedly associated with lower blood
pressure, suggesting a novel role of YAP1 in blood pressure regulation. The overarching goal of this proposal is
to determine the role of YAP1 in regulating both VSMC proliferation and contraction/hypertension. Novel
preliminary data in this proposal include 1) YAP1 expression is upregulated after arterial injury and correlates
with VSMC proliferation in vivo, 2) YAP1, in association with TEA domain transcription factor 1 (TEAD1), induces
platelet-­derived growth factor receptor beta (PDGFRb), a putative novel YAP1 target gene that regulates VSMC
phenotype, 3) SM-­specific Yap1 knockout mice exhibit a hypotensive phenotype and an attenuated response to
vasoconstrictors in isolated vessels, and 4) silencing YAP1 in VSMCs inhibited protein kinase C alpha (PRKCa)
signaling and impaired actin polymerization, which are key for VSMC contraction. Three specific aims are
proposed to test the central hypothesis that YAP1 induces VSMC proliferation and contraction to drive neointima
formation and hypertension, respectively. K99 Aim 1. Test the hypothesis that YAP1 induces PDGFRb to
promote VSMC proliferation and enhance injury-­induced neointima formation in vivo. R00 Aim 2. Test the
hypothesis that YAP1 activates PRKCa signaling and promotes actin polymerization to enhance VSMC
contraction. R00 Aim 3. Test the hypothesis that VSMC-­expressed YAP1 underlies experimental hypertension.
Completion of the proposed studies will provide novel insights into the mechanisms regulating VSMC phenotypic
modulation and blood pressure regulation and will determine if inhibiting YAP1 is an attractive novel therapeutic
strategy for ameliorating both occlusive vascular diseases and hypertension. Additional conceptual and
experimental training in hypertension-­related research during the K99 phase will help the applicant pursue an
independent career and transform this proposal into an R01 application during the R00 phase.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease remains the number one cause of death in the United States and worldwide. The proposed study utilizes a translational approach incorporating the use of transgenic animal models, advanced smooth muscle cell culture techniques, pharmacological strategies and collaborations with leaders in the field to rigorously test the hypothesis that the transcription co- factor yes- associated protein 1 induces smooth muscle proliferation and contraction to drive vascular wall thickening and hypertension, respectively. Completion of the proposed studies will provide novel insights into the mechanisms regulating vascular wall diseases and will determine if inhibiting YAP1 is an attractive novel therapeutic strategy for ameliorating both occlusive vascular diseases and hypertension.